Regulation of headache pain responses by the Trigeminal ganglion clock

PROJECT SUMMARY / ABSTRACT
Pain, often referred to as the “fifth vital sign,” is a universal experience and a major reason to seek medical
intervention. Growing evidence indicates a regulatory role of our biological timer, the circadian clock, in pain
timing and thresholds. Particularly, several headache disorders have been found to display distinct circadian
features, including cluster headache (CH) and migraine. CH is an extremely painful disorder (nicknamed “suicide
headache”), affecting 1 out of every 1,000 people, and is known to exhibit a precise daily rhythmicity of headache
attacks. However, the molecular mechanisms underlying rhythmic pain responses in headache disorders remain
poorly understood. This significant gap in knowledge hinders the development of novel chronotherapeutic
strategies to optimize pain management. To elucidate the circadian regulation of pain responses, we first
examined the trigeminal ganglion (TG), the primary somatosensory ganglion for the canonical headache
pathway, and discovered strong circadian rhythms in TG ex vivo cultures. Using a nitroglycerin (NTG) induced
mouse headache model, we demonstrated circadian rhythms of pain sensitivity which were abolished when the
core clock genes Per1/Per2 were disrupted. TG RNA-sequencing analysis revealed a robust circadian
transcriptome including core clock genes and clock-regulated pain neurotransmitters. Among the most
rhythmically expressed genes in the TG circadian transcriptome, Mertk (MER proto-oncogene, tyrosine receptor
kinase) was recently identified as a CH susceptibility gene in three independent large-scale GWAS studies;
however, its role in pain pathways is completely unknown. We found that NTG induced the phosphorylation of
MERTK (which is required for its tyrosine kinase activity), and importantly circadian pain sensitivity was abolished
in Mertk KO mice, suggesting a role for Mertk to confer circadian timing to pain pathways. Based on these
exciting preliminary findings, we hypothesize that the TG circadian clock governs rhythmic headache responses
via regulation of pain genes including the novel regulator Mertk. Our two specific aims are as follows. In Aim 1,
combining genetic, environmental and pharmacological approaches, we will delineate the regulatory role of the
nociceptive neuron clock in headache pain rhythms and a potential chronotherapeutic application. In Aim 2, we
will investigate the role of MERTK in rhythmic headache responses and identify downstream mechanistic
pathways. This grant proposal embodies conceptual and experimental innovations including circadian regulation
of headache pain and a novel regulatory role of MERTK in the clock-headache crosstalk. With the unique
combination of complementary expertise in circadian biology and headache/CH, we are ideally suited to
interrogate key molecular mechanisms at the interface of circadian rhythms and headache pain. Given the
increasing appreciation of the fundamental function of the clock in pain pathophysiology, our study will have
strong basic and translational impact, and may ultimately lead to a new paradigm of manipulating the circadian
machinery to ameliorate headache pain.

Public health relevance
PROJECT NARRATIVE Pain is a universal human experience, and growing evidence indicates a close crosstalk between circadian rhythms and pain disorders including headaches; however, the underlying molecular mechanism is poorly understood. Based on our recent preliminary results from behavioral, omics and molecular studies, the current proposal aims to investigate the circadian clock function in rhythmic pain responses and delineate the mechanism of a novel circadian regulator of headache pain. This pioneering project will generate seminal functional and mechanistic insights toward understanding the temporal basis of pain, and promote development of new mouse models and chronotherapeutic strategies for headache and other pain disorders.